Developing clinically relevant PET tracers to image T cell activation for improved cancer immunotherapy monitoring

SUMMARY
Chimeric antigen receptor (CAR) T cell therapies represent a major advancement in the cancer immunotherapy
(IOT) field and have shown remarkable success particularly for treating hematologic malignancies. Despite their
meteoric rise, these “living drugs” face a number of challenges that have limited their widespread utility
(especially for solid tumors), including the inability to discern cell fate after infusion. Growing investment in
developing new CAR T cell therapies and the desire to optimize existing ones highlights the urgent unmet need
for techniques that permit non-invasive, longitudinal monitoring of CAR T cell fate. An imaging method
that enables sensitive detection of activated T cells, including CAR T cells, in vivo has the potential to reveal
mechanisms underlying failures, thus enhancing our ability to design and optimize IOTs. Immuno-positron
emission tomography (immunoPET), a rapidly expanding area of molecular imaging that combines ultra-specific
antibodies or antibody fragments with PET radioisotopes, has enormous potential to shed light on the in vivo
spatiotemporal distribution and functional status of CAR T cells. Unfortunately, there are no clinically approved
gold-standard immunoPET radiotracers, or other imaging techniques, that target T cell activation markers.
Recently, we identified OX40 and ICOS (two cell-surface antigens that are highly and specifically upregulated
on activated T cells) as promising biomarkers for imaging T cell responses. Subsequently, we developed the first
PET radio
tracer
s to image murine OX40 and ICOS by radiolabeling monoclonal antibodies (mAbs) with 64Cu or
89Zr and demonstrated their utility for quantifying and tracking activated T cells in a variety of cancer IOT models.
We also verified that both OX40 and ICOS are significantly upregulated on activated human and murine CD19-
CAR T cells, and that ICOS immunoPET enables visualization of the latter in vivo. In this R01, we propose to
build on our promising preclinical data by developing the first human-specific radiotracers for OX40 and ICOS,
utilizing mAbs and F(ab’)2 fragments. We have performed preliminary 89Zr- radiolabeling of human-OX40 and -
ICOS mAbs and demonstrated their specificity for human activated T cells. Additionally, we have acquired highly
encouraging in vivo imaging and stability data for our novel human OX40-mAb radiotracer. Aim 1 involves
optimizing radiolabeling for ICOS and OX40 mAbs, generating and labeling F(ab’)2 fragments, in addition to
thoroughly assessing stability, affinity, and immunoreactivity of all four new radiotracers. We will then investigate
potential biological effects and in vivo binding of these radiotracers to activated human T cells (Aim 2) and to
CAR T cells, the latter engineered to target liquid and solid tumors (Aim 3). Finally, we will assess the safety of
these radiotracers for CAR T cell imaging (Aim 3). Completing these experiments will provide invaluable data on
the sensitivity and specificity, as well potential biologic effects, of all four imaging agents, guiding their
optimization for our long-term goal of clinical translation. Such OX40 and ICOS PET radiotracers will afford a
new approach for monitoring CAR T cells and other IOTs with great potential to increase their clinical success.

Public health relevance
NARRATIVE While chimeric antigen receptor T cell (CAR T) therapy represents a major advancement in the cancer immunotherapy field, these ‘living drugs’ face several barriers to their widespread success, including the inability to discern their fate after infusion. Here we propose a new in vivo approach to monitor CAR T cells with high specificity using immuno-positron emission tomography (immunoPET), a rapidly expanding area of molecular imaging. Specifically, we will develop and characterize the first human-specific immunoPET probes for OX40 and ICOS, two cell-surface antigens that are upregulated on activated T cells (including CAR Ts) with the long- term goal of clinical translation to improve patient outcomes by enabling non-invasive monitoring of responses to CAR T and other immunotherapies.